Balance and Auditory Research Center (BARC)

Project Summary for the Balance and Auditory Research Center (BARC)
Vestibular and auditory functions are fundamental to survival and quality of life. Childhood hearing loss is the
most common congenital disorder, estimated to affect 2-3 in every 1000 births, and often co-morbid with
vestibular impairment. Balance impairment and falls are among the most prevalent and morbid conditions
affecting older adults, the most common cause of traumatic brain injury. Hearing loss is the third most common
chronic health condition and one of the strongest modifiable risk factors for cognitive decline and dementia. The
repercussions of balance and hearing disorders for mortality and morbidity are just now reaching a new level of
recognition. Yet, balance and hearing are largely uninvested areas of neuroscience, which has contributed to the
lack of translation of medical interventions for balance and hearing disorders. Understanding the genetic,
structural, and neurophysiological mechanisms underlying balance and hearing disorders is essential for
developing innovative diagnostic tools, therapeutic strategies, and rehabilitation techniques for patients. The goal
of establishing the Balance and Auditory Research Center (BARC) at the University of Mississippi Medical
Center (UMMC) is to build a critical mass of independent investigators to develop effective diagnostic and
therapeutics for balance and auditory disorders. BARC will be built upon a solid core of well-supported and
established neuroscientists in vestibular and auditory research. BARC has three specific aims: (1) foster a
research environment that supports collaborative and innovative vestibular and auditory neuroscience research;
(2) develop research capacity to conduct state-of-the-art vestibular and auditory neuroscience research through
development of two research cores and additional faculty positions: and (3) nurture a group of early stage and
new investigators to become independent researchers in the field of vestibular and auditory research.

Public health relevance
PROJECT NARRATIVE By recruiting new faculty and fostering independence of junior faculty, the Balance and Auditory Research Center will greatly facilitate the process of reaching a critical mass of independent investigators to develop a competitive national center for balance and auditory research at the University of Mississippi Medical Center.